MOTHERS &NEWBORNS STUDY

This molecular epidemiologic cohort study of African American and Hispanic mothers and newborns is investigating the role of polycyclic aromatic hydrocarbon and environmental tobacco smoke in procarcinogenic and develop-mental damage. A combination of personal monitoring, questionnaire and biomarkers in peripheral blood will be used to quantify individual exposure to toxicants of concern. Measures of development will be assessed at 6 and 12 months.